Extending the Prevention Toolbox: Exploring the Acceptability and Impact of Long-acting Injectable PrEP among MSM in Baltimore: A Pilot Study

PROPOSAL SUMMARY
The incidence of HIV in Baltimore, MD is among the highest in the US, with men who have sex with men (MSM)
bearing a disproportionate burden of the disease. As we enter the “95-95-95” era of the Joint UN Program on
HIV/AIDS (UNAIDS) Fast Track targets, research into innovative approaches that extend the prevention toolbox
is needed. Long-acting (LA) cabotegravir (CAB) for HIV pre-exposure prophylaxis (PrEP) was recently approved
by the FDA based on data that demonstrated superiority to tenofovir disoproxil fumarate (TDF)/emtricitabine
(FTC). LA PrEP may help overcome key challenges of oral PrEP by increasing PrEP use/uptake, particularly
among key populations, such as MSM. Furthermore, much research has shown that social and structural
determinants of health (SSDoH), such as poverty, racism, access, homonegativity and discrimination and
individual and community-level factors, such as stigma, knowledge, and perception towards PrEP shape access
and uptake of PrEP among MSM individuals. Studies to date have explored the acceptability of LA PrEP as a
hypothetical option among MSM; however, since the FDA approval of LA CAB in December 2021, little is known
about perceptions and acceptability of LA PrEP in high-risk MSM communities and its relation to sexual network
structures (e.g., how do the perceptions and behaviors of one’s contacts influence one’s own perception of LA
PrEP). Further, even among those on oral PrEP, little is known about the knowledge, acceptability, and
preference of daily tenofovir alafenamide (TAF) vs. TDF-based regimens and further still, daily oral PrEP vs.
TDF/FTC 2-1-1 (on-demand) PrEP, which was not included in CDC guidelines until 2021. The applicants
proposed study, Extending the Prevention Toolbox: Exploring the Acceptability and Impact of Long-acting
Injectable PrEP among MSM in Baltimore: A Pilot Study will address this gap. This study will gather data on
community preferences for PrEP choices among MSM in Baltimore and use this information to inform messaging
and support mechanisms, as well as generate data on behaviors and networks to inform epidemiological models
and policies to reduce barriers to PrEP. This will be accomplished through the following aims: Aim 1: To use
thematic analysis from the parent study focus group interviews, to refine a cross-sectional survey including a
DCE module for PrEP preferences with random allocation of attributes (i.e., cost, side-effects, effectiveness,
insurance coverage etc.) within each PrEP choice set. Aim 2: To characterize MSM sexual networks in Baltimore
(N=500) to determine the impact of predisposing, enabling, and perceived need factors on PrEP use/uptake.
Aim3: To evaluate how sexual network characteristics impacts PrEP use/uptake and preferences among MSM;
H1: The use/uptake of PrEP is positively associated with PrEP use within sexual networks and H2: PrEP
preferences, as determined in the DCE are positively associated with sexual network partner preferences. This
innovative study builds on over many months of preliminary work of conducting focus groups and qual data
analysis for the parent study. It establishes a foundation for future studies to evaluate the role of LA PrEP in
MSM communities to implement an informed PrEP strategy.

Public health relevance
PROJECT NARRATIVE This proposed study aligns with NIAIDs Research’s Strategic plan which highlights the crucial need to build on scientific progress and opportunities for advancing HIV/AIDS research and stimulate innovative discovery to prevent new HIV infections to put an end towards the HIV pandemic. Social and structural determinants of health (SSDOH) contribute to the disparate impact of PrEP use/uptake on MSM communities, and this innovative study will further inform our understanding of individual and network levels factors that have been less explored in this population. With an enhanced understanding of how behaviors and networks influence PrEP management among MSM with an interplay of SSDOH factors, we are better positioned to guide the development of interventions aimed at promoting health equity and enhancing PrEP uptake among individuals at risk of acquiring HIV.